AI-driven Drug Discovery Targeting Cardiac Fibrosis in Aging Heart

Project Summary
Cardiac fibrosis, a hallmark of aging, leads to tissue stiffness, impaired cardiac function, and heart failure,
significantly reducing quality of life in elderly populations. Despite its clinical burden, no FDA-approved therapies
exist for treating cardiac fibrosis, underscoring an urgent need for innovative solutions. This UG3/UH3 study
aims to discover and validate novel antifibrotic compounds by leveraging cutting-edge technologies, including
human induced pluripotent stem cells (iPSCs), artificial intelligence (AI), and advanced preclinical models. The
UG3 phase will focus on high-throughput screening (HTS) of over 225,000 compounds using iPSC-derived
cardiac fibroblast (iPSC-CF) reporter lines to identify lead candidates. The ADMET-AI platform will filter these
candidates for favorable drug-like properties and low toxicity. In the UH3 phase, selected compounds will
undergo robust in vitro and in vivo validation. This includes testing in “cell villages” for population-scale
evaluations and 3D cardiac organoids to assess efficacy and safety in tissue-like environments. The top two hits,
including a repurposed drug and a novel compound, will be tested in aging mice to examine their therapeutic
potential in restoring cardiac function and reducing fibrosis. This multidisciplinary approach integrates fibrosis
research, AI/ML tools, and iPSC technology to address a critical unmet need in aging cardiovascular health. By
targeting senescent fibroblasts and employing innovative drug screening platforms, this UG3/UH3 study has the
potential to advance the discovery of effective antifibrotic therapies, paving the way for clinical translation and
improving outcomes in aging populations.

Public health relevance
Project Narrative This UG3/UH3 project aims to develop novel therapies for cardiac fibrosis, a leading cause of heart failure in aging populations. By integrating iPSC models, AI-driven drug discovery, and preclinical validation, this study will identify both a novel and a repurposed compound targeting senescent fibroblasts to reverse fibrosis. The findings will advance antifibrotic drug development, improve aging cardiovascular health, and address a critical gap in therapeutic options.